The cardiovascular consequences of sleep apnea plus COPD (Overlap syndrome)

Abstract
Chronic obstructive pulmonary disease (COPD, which includes chronic bronchitis and
emphysema) and obstructive sleep apnea (OSA) are both common diseases with major
cardiovascular sequelae. The concomitant presence of COPD and OSA is referred to as overlap
syndrome (OVS), which has a very poor prognosis with his risk of cardiovascular mortality. Our
data demonstrate an association between OSA treatment and improved mortality in individuals
with OVS, but to date data are not definitive and underlying mechanisms are undefined. In theory,
in individuals with baseline (sustained) hypoxemia, further intermittent hypoxemia due to OSA
may promote pulmonary vasoconstriction and elevated pulmonary vascular resistance. Thus, the
right ventricle (RV) may be particularly affected by OVS. Of note, we have robust preliminary data
showing the impact of OVS on the RV and reversibility with intervention. To investigate these
concepts further, we propose two specific aims. First, we will perform a cross-sectional study to
compare specific markers of cardiovascular risk among those with OSA vs. COPD vs. OVS. This
aim will test the hypothesis that OVS has worsen endothelial function as compared with
individuals afflicted with either disease alone. We will quantify other markers of cardiovascular
risk such as cardiac MRI and plasma biomarkers including novel microRNAs. We have recent
prominent publications suggesting a major role of miR-210 in the pathogenesis of OSA induced
vascular risk. We will also employ novel imaging methods to assess potential biomarkers for
mechanistic insights and to identify robust surrogate outcome measures for subsequent studies.
Second, we will perform a mechanistic clinical study to compare the improvement in RV mass
among individuals who receive bi-level positive airway pressure (PAP) as compared to individuals
who receive oxygen (O2), which is the current standard of care. This aim will test the hypothesis
that bi-level PAP therapy improves markers of cardiovascular risk as compared with O2 therapy.
In addition to cardiac MRI we will assess other biomarker of cardiovascular risk as in Aim 1. Such
findings will lay the groundwork for a multicenter randomized controlled trial, which we believe will
be required to change the current standard of care. Our proposal will also inform basic research
on the interactions of sustained plus intermittent hypoxemia. Given the high vascular risk among
these individuals, the very high population prevalence of disease and the lack of current data,
further mechanistic research is imperative.

Public health relevance
Narrative Report Obstructive sleep apnea (OSA) and chronic obstructive pulmonary disease (COPD) are major public health problems. More work is needed to understand how to reduce the risk of heart attack and stroke in these patients particularly in people who have the overlap syndrome (OVS) of OSA plus COPD. Our research will help to raise awareness regarding OVS and how best to address OVS in individuals at risk of these complications.